Interrogating genome folding trajectories in health and disease

Project Summary
Detection and identification of the astronomical number of volatile chemicals that we perceive as odors
depends upon the monogenic and monoallelic expression of olfactory receptor (OR) genes in olfactory sensory
neurons (OSNs). An intricate network of OSN-specific interchromosomal interactions coordinates the
transcriptional activation of only 1 OR allele out of >2000 OR alleles distributed across 18 different
chromosomes. Genomic interactions between silent OR genes assemble heterochromatic multi-chromosomal
compartments that keep OR genes transcriptionally inactive, whereas genomic interactions between intergenic
OR enhancers result in a multi-chromosomal enhancer hub that activates singular OR transcription. Here, we
propose to combine Dip-C, a variation of single cell HiC, with viral-based cell tagging technologies, towards the
identification of genome folding intermediates across OSN differentiation lineages. This “cradle to crate”
genomic analysis will follow individual OSN progenitors and their barcoded progeny, allowing a complete
cartography of genomic interactions made by every OR allele en route to transcriptional activation. Single
molecule DNA FISH experiments will complement the proposed genomic studies, providing high resolution
insight to the genomic choreography that orchestrates singular OR gene choice during development. Finally,
we seek to explore how the trajectories of OSN genomic folding become altered and eventually disrupted in a
humanized model for Alzheimer’s disease (AD). Olfactory dysfunction, hyposmia, and anosmia constitute well-
established prodromal symptoms of AD, but the molecular etiology of this intriguing connection is not known.
Using a humanized model for AD we discovered that interchromosomal OR compartments dissipate prior to
the onset of neurodegeneration, resulting in strong downregulation of OR transcription. Thus, we propose to
apply our single cell interrogation of genome folding transition in the context of AD and to establish the
baseline of nuclear architecture in human OSNs. Deciphering how OR compartments assemble in health, and
how they become disrupted in disease, may provide the basis for novel prognostic and diagnostic tools for AD,
and molecular assays for in vivo screening of AD therapeutics.

Public health relevance
Project Narrative Genomic organization in the 3-dimensional nuclear space emerges as a new epigenetic regulator of transcriptional specificity that affects various developmental processes. The olfactory system provides an ideal system for deciphering, in vivo, the developmental intermediates of genomic compartmentalization and for obtaining structural insight into compartments with critical roles in neuronal gene regulation. Importantly, by revealing that genomic compartments dissipate in a humanized model of Alzheimer’s disease, not only do we explain the long-standing puzzle of olfactory deficits as a prodromal symptom of neurodegeneration, but we also open new routes for prognoses and pharmaceutical screens based on nuclear architecture perturbations.